Chemical Mixtures Core

CORE SUMMARY – CHEMICAL MIXTURES CORE
Superfund sites contain mixtures of many contaminants. The US EPA Supplemental Guidance for Conducting
Health Risk Assessments of Chemicals stated that “approaches based on whole mixtures are preferred to
component approaches”. The research community needs robust, analyte-rich methods suitable for complex
matrixes. The scientific community needs new, specialized, more sensitive methods to separate, detect, and
quantify dozens of polycyclic aromatic hydrocarbons (PAHs) and substituted PAHs with widely varying
concentrations and chemical properties in complex, heterogeneous matrices. These challenges continue to
drive the development of analytical methods for PAHs, substituted PAHs and PAH transformation products, as
well as Superfund co-contaminants. It is demanding to analyze PAHs and x-PAHs in environmental and
biological matrices because the samples are complex, the numerous isomers of alkylated and high-molecular-
mass compounds are often difficult to differentiate, and we often lack standards and suitable reference
materials. The primary goal of the Chemistry Mixtures Core (CMC) is to support other Superfund Center
projects and cores. We will maximize their access to quality-assured quantitative analytical technologies and
empower them to increase their creativity and knowledge. We will create new and improved methods for
PAHs, PAH metabolites, and substituted PAHs (e.g., alkyl-, oxygen- and nitrogen- substituted PAHs). We will
collaborate with the Data Management and Analysis Core (DMAC) to improve our unique web-based interface
for requesting standards, certified reference materials and submitting samples. We will develop and improve
our high-volume data production and management platform. We will expand the 1,530-analyte screen by
continuing to develop reductionist methods for mixture analysis. We will create bioavailable real-world
reference materials from Superfund soil, sediment and water extracts in collaboration with the environmental
projects and provide these materials to the biological projects. We will provide web-based training material for
analytical methods and bio-analytical technologies to center investigators and trainees.

Public health relevance
CORE NARRATIVE – CHEMICAL MIXTURES CORE The Chemical Mixtures Core develops new analytical methods and provides robust and sensitive analytical methods for substituted PAHs, PAH degradation products and co-contaminants at Superfund sites. The CMC creates PAHs mixtures, PAH real-world Superfund reference materials, and provides standards and dosing solutions for the SRP. The CMC provides all analytical methods through technology transfer to SRP laboratories and interested stakeholders.